A holistic approach to identifying functional units of tongue motion during speech

PROJECT SUMMARY
Oral cancers have the seventh highest incidence, with roughly 51,540 new cases and 10,030 cancer-
related deaths expected to occur in 2018. Although a variety of treatment methods are available, the death rate
is higher than that for most cancers with five-year rates of about 50 percent. The most frequently used
treatment method, glossectomy surgery, involves the surgical removal of tumors and surrounding tissues, and
the addition of grafted tissues, often followed by radiotherapy. Although tongue cancer and its treatment have
debilitating effects on speech, the impact of varying degrees of resection and reconstruction on the formation
of functional units in speech has remained poorly understood. In order to produce intelligible speech, a variety
of local muscle groupings of the tongue—i.e., functional units—emerge and recede rapidly and nimbly in a
highly coordinated fashion. Therefore, understanding the formation of functional units that are critical for
speech production can provide substantial insights into normal, pathological, and adapted motor control
strategies in controls and patients with tongue cancer for novel therapeutic, surgical, and rehabilitative
strategies. One of the critical challenges in pre-operative surgical and treatment planning, as well as in post-
operative evaluation for tongue cancer is the difficulty in developing objective and quantitative measures and in
evaluating their functional outcome predictability. To address this, in this proposal, three integrated approaches
will be used in in vivo tongue motion during speech to seamlessly identify the functional units and associated
quantitative measures: multimodal MRI methods, multimodal deep learning, and biomechanical simulations.
This will provide a convergent approach, thereby allowing us to (1) test hypotheses about the spatiotemporal
basis of muscle coordination in a consilient way, and (2) develop objective quantitative measures that are
required for understanding the complex biomechanical system as well as for predicting the functional outcomes
after various reconstruction methods. The first proof of concept study published by the PI and the team
identified the functional units of speech tasks using the sparse non-negative matrix factorization framework, in
which the magnitude and angle of displacements from tagged MRI were used as our input quantities. With
these advances in place, we will further incorporate muscle fiber anatomy from diffusion MRI and motion
tracking from tagged MRI into our framework to yield physiologically and anatomically meaningful functional
units. In addition, we will create a completely novel and integrated way of directly relating the functional units to
tongue muscle anatomy, learning joint representation via a multimodal deep learning technique, and linking
them to biomechanical simulations. Furthermore, 3D and 4D atlases will be utilized to identify objective and
quantitative measures based on our functional units analysis. Taken together, the successful implementation of
our integrated framework will identify functional units that can be used for research on tongue motion, for
surgical planning, and for diagnosis, prognosis, and rehabilitation in a range of speech-related disorders.

Public health relevance
PROJECT NARRATIVE Tongue cancer and its treatment affect tongue structure and function, yet little is known about how the changes in tongue structure due to varying degrees of resection and reconstruction affect the formation of functional units of tongue motion during speech. We propose to use novel integrated platform tools to identify functional units seamlessly with unprecedented resolution and precision. Upon success of this proposal, our integrated framework has the potential to aid in an increased understanding of speech motor control strategies in healthy controls and the patient group, thereby benefiting patients through improved diagnosis, treatment, and rehabilitative strategies.